"CRCNS": Brain-derived network architectures for deciphering and applying brain algorithms

Our LONG-TERM GOAL is to extend current biological and artificial vision research from a focus on 2D
image recognition toward visual understanding of 3D structure in the real world. 3D object perception is the
essence of real-world vision, underlying the “thousand words” of information the brain generates about
precise object geometry on large and fine scales, structural design, mechanics, material composition,
biological morphology and functionality, physical state, pose, mass distribution, balance/support against
gravity, potential for movement from passive falling/rolling to self-generated motion and complex interactive
behaviors, age, beauty, damage, value, etc.
Our first AIM is to use artificial vision networks to decipher brain algorithms underlying biological 3D
vision. We will train novel, analyzable network architectures developed for 3D vision by the Yuille lab, to
replicate 3D shape tuning functions of individual neurons recorded in the Connor lab, from successive
stages of object processing in macaque monkeys: area V4, posterior inferotemporal cortex (PIT) and
anterior inferotemporal cortex (AIT). The Connor and Yuille labs will analyze the 3D shape processing
algorithms learned by these neuron-trained networks (NTNs), tracing the pathways of information from V1-
like 2D Gabor filters in layer 1 to the output neuron response, using a novel method for back-tracing the
sources of excitatory and inhibitory signals through the network.
Our second AIM is to develop artificial networks that implement biological algorithms to achieve human-
level 3D visual performance. The Yuille lab will build on preliminary work proving the potential of novel
network architectures performing analysis-by-synthesis with Neural Textured Deformable Meshes
(NTDMs). These networks are designed for internal reconstruction of and high-level inference from 3D
shape in natural scenes. The Connor lab will use components of these networks, in addition to more
standard architectures like AlexNet, to train using neural responses (AIM 1). The trained network
components and algorithms deciphered from them (AIM 1) will be incorporated by the Yuille lab into their
evolving NTDM network designs to search for higher performance on larger 3D shape domains under a
variety of real-world viewing conditions. Training and testing in larger 3D shape domains will depend on a
unlimited photorealistic 3D ground truth-parameterized stimuli produced by genetic algorithms developed
by the Connor lab (PRGAs).
RELEVANCE (See instructions):
This study aims to understand the neural algorithms that underlie visual understanding of 3D structure in
the real world and apply those algorithms in artificial visual systems. Understanding these neural algorithms
is relevant for future prosthetic approaches to restoring 3D visual experience through cortical implants.
Using these algorithms to bring artificial vision closer to biological vision will be essential for intelligent
driving of such prosthetics based on camera images.

Public health relevance
RELEVANCE (See instructions): This study aims to understand the neural algorithms that underlie visual understanding of 3D structure in the real world and apply those algorithms in artificial visual systems. Understanding these neural algorithms is relevant for future prosthetic approaches to restoring 3D visual experience through cortical implants. Using these algorithms to bring artificial vision closer to biological vision will be essential for intelligent driving of such prosthetics based on camera images.